The role of NOD2/RIPK2 signaling in the pathogenesis of Parkinson's Disease

PROJECT SUMMARY

Growing evidence suggest that central nervous system (CNS) inflammation is a major pathophysiological
process in Parkinson’s disease (PD). The inflammation is characterized by an increase in the number of microglia
and in the levels of proinflammatory cytokines and chemokines. The proinflammatory cytokines, which are
released when microglia are activated, could exacerbate α-­synuclein (α-­syn) aggregation and neuronal death
ultimately driving the chronic progression of PD. Dying or dead dopaminergic neurons released α-­syn aggregates
can be taken up into the microglia, which leads to microglia activation. This in turn contributes to the accelerated
progression of neurodegenerative processes. Therefore, identification of molecular targets in microglia that can
be modulated to inhibit their inflammatory response may provide new strategy for the treatment of PD. However,
there is a lack of knowledge about the cellular mechanisms underlying microglia-­mediated neuroinflammatory
events following stimulation with α-­syn aggregates. To gain a comprehensive understanding of the cellular
mechanisms of α-­syn aggregates induced microglial activation, we conducted RNAseq analysis using α-­syn
preformed fibrils (α-­syn PFF) activated microglia. From the screening, we identified NOD2/RIPK2 complex as a
key modulator in neuroinflammatory responses due to α-­syn aggregate. In our preliminary studies, we found that
α-­syn aggregates activate NOD2/RIPK2 mediated inflammatory responses in microglia to exacerbates neuronal
death through a series of signaling events, which included M1 microglial activation and toxic A1 type astrocytes
conversion by secreting IL-­1α, TNFα and C1q. On the other hand, we found that the depletion of NOD2/RIPK2
complex protects neuronal death via blocking microglia-­mediated A1 astrocyte conversion in vitro and in vivo.
To further confirm and expand our novel preliminary findings, we will systematically pursue the following specific
aims: (i) to define the levels of NOD2, RIPK2 mRNAs and proteins and the levels of phosphorylation of RIPK2
in microglia in mouse models of α-­syn induced degeneration and PD postmortem brains, ii) to characterize the
interaction between NOD2 and α-­syn aggregates in microglia and define how α-­syn PFF binding to NOD2 affects
NOD2/RIPK2 dependent signaling pathways including RIPK2 activation/ubiquitination and MAPKs and NF-­kB
activation in microglia, iii) determine the depletion effect of NOD2/RIPK2 signaling in microglia-­induced A1
astrocytes formation due to α-­syn aggregates both in vitro and in vivo, and (iv) to determine the effects of blocking
of NOD2/RIPK2 signaling in α-­syn PFF induced model of PD through genetic ablation of NOD2 and RIPK2 and
pharmacological inhibition of RIPK2. Cellular, neurochemical, neuropathological and behavioral approaches in
vitro and in vivo will be used to achieve these specific aims. Taken together, understanding the role of
NOD2/RIPK2 dependent signaling in α-­syn aggregates-­induced microglial activation, A1 astrocyte conversion
and DA neuronal death will not only provide novel mechanistic insights into the progression of neurodegenerative
processes in PD, but also ultimately lead to the development of new therapeutic strategies for PD.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Defective control of inflammation in the central nervous system results in a devastating impairment of neural function and contributes to the progression of neurodegenerative processes in Parkinson’s disease. Understanding the basic cellular and molecular mechanisms that regulate and inhibit neuroinflammation is therefore of utmost importance to improving public health.